Plan and Conduct the Hampton University Skin of Color Research Institute Skin of Color Symposium 2015

? DESCRIPTION (provided by applicant): This application is requesting funds for partial support of the HUSCRI Skin of Color Symposium 2015: From Bench to Bedside, to be held in Williamsburg, Virginia at the Williamsburg Lodge, November, 13-15, 2015. The symposium has grown since its inception, and we attribute the success of the prior meetings to the partial support received from NIH through NIAMS and the NIH Office of Rare Disease Research. This conference is designed to promote, develop and advance the education, knowledge, and research of cutaneous disorders which disproportionately impact racial and ethnic minorities. Centered on the theme of From Bench to Bedside, the proposed symposium provides a program featuring a diverse panel of nationally recognized physician-scientists, basic scientists and clinicians who will provide attendees highlights of the latest research advances across multiple relevant disciplines including public health, basic science, and the clinical diagnosis an management of select, complex and rare dermatologic conditions. The scientific sessions selected for the HUSCRI symposiums 2015 are focused on gaining a more in- depth of knowledge of vitiligo, pigmentary disorders, keloids, cutaneous lupus and cicatricial alopecia. The symposium will also feature a grant writing workshop designed to assist junior investigators (particularly minority investigators) on how to prepare proposals to successfully compete for extramural grant funding. Objectives of the grant writing session are to: 1)increase the success of junior/new investigators including minority investigators in securing funds by providing grant preparation assistance and direct feedback on ongoing research proposals; 2)support the attendance of minority junior investigators to the seminar and symposium through the provision of travel awards and; 3)facilitate the interaction and networking of junior investigators with senir members of the scientific and clinical community. We expect that the scientific sessions, short talks, and grant writing workshop combined with the synergistic environment that has characterized this conference in the past will spur the formation of new collaborations, scientific discovery, and ultimately culminate in novel treatments for dermatologic disorders disproportionately affecting individuals with skin of color

Public health relevance
PUBLIC HEALTH RELEVANCE: The HUSCRI Skin of Color Symposium 2015: From Bench to Bedside is designed to increase awareness, and advance the knowledge, and spawn new research (basic and clinical) of skin disorders which disproportionately impact racial and ethnic minorities. The proposed symposium provides a program comprised of a diverse panel of nationally recognized physician-scientists, basic scientists and clinicians who will update attendees on the latest research advances across multiple relevant disciplines including public health, basic science, and the clinical diagnosis and management of complex and rare select dermatologic conditions. We expect that the interactive and collegial environment that has characterized this conference in the past will spur the formation of new collaborations, expand scientific discovery in related research, and ultimately culminate in the formation of novel treatments for individuals with skin of color and dermatologic disease. Project Summary This proposal is requesting funds for partial support of the HUSCRI Skin of Color Symposium 2013: From Bench to Bedside, to be held in Baltimore Maryland at the Harbor Court Hotel, October 25-27, 2013. The symposium has steadily grown since its' inception, and the 2013 symposium will capitalize on a multi-institutional collaboration between the HUSCRI, and the Departments of Dermatology at University of Maryland Medical Center and Eastern Virginia Medical School. The proposed symposium is designed to promote, develop and advance the education, knowledge, and research of cutaneous disorders which disproportionately impact racial and ethnic minorities. Centered on the theme of "From Bench to Bedside", this Symposium will provide an educational program with a diverse panel of nationally recognized physician-scientists and basic-scientists who will provide the most current information of advances in research across multiple relevant arenas including medical dermatology, public health, and basic science. The session topics selected for the HUSCRI Symposium 2013 are focused towards gaining a greater depth of knowledge of disparities in access to dermatological care and the latest findings in the basic etiological mechanisms, and therapeutic interventions for, selected inflammatory skin disorders, pigmentary disorders, and keloids. The symposium will also feature a concurrent grant writing seminar designed to assist junior investigators (particularly minority investigators) on how to successfully write a research proposal and compete for extramural grant funding. Objectives of the grant writing symposia are to: 1)improve the success of new investigators including minority investigators in securing funds by providing grant writing assistance and direct feedback on ongoing research proposals from the experts in the field of grant writing; 2)support attendance of minority junior investigators to the seminar an symposium through the provision of travel fellowships and; 3)Facilitate the interaction and networking of junior investigators with senior members of the scientific and clinical community We expect that symposium activities, including the scientific presentations, grant writing seminar, poster sessions, and other informal interactions amongst symposium attendees will encourage the development and increase the number of clinical, basic, and epidemiological research studies and collaborative projects in this field. This will lay the groundwork for the development of novel and improved therapeutic treatments thereby fulfilling an unmet and critical need for individuals with skin of color and dermatologic disease.